The Ghana Randomized Air Pollution and Health Study (GRAPHS) Cohort

Project summary
Worldwide, ~2.8 billion people are exposed daily to smoke from cooking fires, termed household air pollution
(HAP), resulting in an estimated 2.3M deaths and 91.4M disability adjusted life years in 2019. The GRAPHS
cohort is longitudinally following mother-child dyads from pregnancy through adolescence to understand how
HAP exposures during critical windows influences lifelong health. To realize the maximum scientific potential of
the GRAPHS cohort, we will expand and improve data collection around key environmental justice topics such
as climate and ambient air pollution; enhance ongoing outreach activities to further strengthen community
partnerships and cohort retention; and improve data management to enable broad data sharing. The proposed
activities will position the GRAPHS cohort as a significant resource for expanding the environmental health
sciences workforce in Ghana and beyond.

Public health relevance
Project Narrative The proposed activities will position the GRAPHS cohort as a significant resource for expanding the environmental health sciences workforce in Ghana and beyond. In the long-term, this work will help inform cost-effective policies and public health interventions that may be applied to critical windows to promote optimal development and improve health.